PARATHYROID FUNCTION DURING RENAL FAILURE

The purpose of this study was to study the effects of chronic renal failure and changes in ionized and total calcium concentrations on intact PTH levels. Clinfo only.